Sable Systems Promethion Core system

PROJECT SUMMARY/ABSTRACT
Obesity and associated metabolic disorders are among the most common and costly health concerns
confronting Western nations. The University of Washington (UW) has been a pioneer in cutting-edge research
into mechanisms regulating energy homeostasis and how defects in this system contribute to these disorders.
Integral to this research effort are support services provided to the research community by the NIDDK-funded
Nutrition Obesity Research Center (NORC). The mission of the UW NORC is to support research in nutrition
and obesity, enhance our understanding of causal mechanisms and identify novel, effective and safe
treatments for these disorders. In support of this mission, the UW NORC Energy Balance Core has provided a
research core infrastructure to investigators for over 20 years that allows comprehensive assessment of
energy balance via the simultaneous measurement of energy expenditure, energy intake, substrate utilization
and physical activity in rodent models. This S10 grant application seeks to upgrade, expand and transform our
capacity to support metabolic research by requesting funds to purchase a new, state-of-the-art 16 cage
Promethion Core indirect calorimetry System from Sable Systems International. Our original Columbus
Instruments OxyMax indirect calorimetry system is no longer operational and our current 16 cage Sable
Systems Promethion Core system is sufficiently old (>13 years) that several parts necessary for routine
maintenance and repair are no longer supported by the company. In the coming months, therefore, the very
real possibility exists that we will no longer be able to either support funded research or honor commitments
made (in the form of letters of support supplied to investigators for inclusion in their NIH grant proposals). At
the same time, demand for our services currently exceeds capacity, resulting in long wait times that further limit
productivity. To address these concerns, we request funding to support the purchase of new equipment that
will not only increase throughput, reducing wait times and improving scientific productivity, but also offer
exciting new capabilities while ensuring that commitments made to our research community are honored.
Specific features of the new equipment we seek include 1) computer-controlled food access hoppers to allow
for pair-feeding or time-restricted feeding studies, 2) metabolic cages designed for use with optogenetics and
other sophisticated neuroscience techniques such as fiber photometry that enable manipulation and/or
monitoring the activity of discrete neuronal populations while also quantifying energy balance, and 3) a stable
isotope gas analyzer for the measurement of 13C and 18O in exhaled breath for precise assessments of
substrate oxidation from exogenously- or endogenously-labeled sources. Together, these new capabilities will
allow the NORC to further expand its research base and support novel science endeavors that are currently
not possible, thereby generating new insights into the pathogenesis of obesity and related metabolic disorders.

Public health relevance
PROJECT NARRATIVE Advances in understanding of energy balance regulation and mechanisms underlying obesity pathogenesis requires approaches that enable effective and accurate measures of energy expenditure, energy intake, substrate oxidation and physical activity. For more than two decades, the University of Washington Nutrition Obesity Research Center (NORC) Energy Balance Core has provided investigators with access to state-of-the- art rodent metabolic phenotyping services for studies related to nutrition, obesity and metabolism using a metabolic cage system that has not kept up with technological advances, and is no longer repairable, should a system failure occur. In this application, we request funding to purchase a new Sable Systems Promethion Core system, which will dramatically improve throughput of services provided to our investigators; provide several new and exciting capabilities, including the ability to interface with sophisticated neuroscience technologies, use of stable isotopes to measure substrate oxidation, and computer-controlled food access; and ensure that existing commitments to our research community are honored while offering state-of-the art support to the greater UW scientific community.